Synthesis and Evaluation of Prp-Specific Probes and Prodrugs

Project Summary/Abstract
New antibiotic targets are needed to combat antibiotic-resistant bacteria. A new potential drug target is a
phage-related ribosomal protease (Prp), which is used by a variety of Firmicutes pathogens such as
Staphylococcus aureus, Streptococcus pneumoniae, and Clostridioides difficile. These pathogens use Prp for
ribosomal maturation. Prp is a cysteine protease that cleaves an N-terminal extension of the ribosomal protein
L27, and in the case of S. aureus, Prp is essential for survival. Since most bacteria do not contain this N-
terminal extension on L27 and do not encode Prp, targeting it should lead to less killing of commensal bacteria
that are important for human health.
Different pathogens that use Prps have distinctive L27 cleavable sequences. In this proposal, we will study
the cross-selectivity and kinetics of L27 sequence cleavage by different Prps. We will identify the minimal L27
N-terminal sequence required for recognition and processing by Prp, and the L27 N-terminal sequence length
required for cross-species Prp selectivity. These lessons will be applied to the synthesis of Prp activated
prodrugs of ciprofloxacin and eperezolid. These prodrugs will be tested for activity and selectivity against the
Prp-containing pathogens S. aureus, S. pneumoniae, and C. difficile, as well as the Prp-containing commensal
bacteria Lactobacillus rhamnosus. These studies will greatly increase our knowledge of the selectivity and
reactivity of Prps, and allow for the targeted killing of bacteria that use them.

Public health relevance
Project Narrative Many pathogenic bacteria including Staphylococcus aureus, Clostridioides difficile, and Streptococcus pneumoniae use an enzyme called phage-related ribosomal protease (Prp) during ribosomal assembly. In this proposal we pursue kinetic and selectivity studies among different Prps, and an approach of using Prp to activate antibiotic prodrugs. This will allow for the selective killing of pathogens that use Prp.